TECHNOLOGY TRANSFER-OPTICS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The technology transferred in Core IV relate to the following issues: 1) Details about how to build Diffuse Correlation Spectroscopy instrumentation and probes, 2) Details about how to build Diffuse Correlation Spectroscopy instrumentation and probes (focus on laser systems), 3) Diffuse optical tomography image reconstruction software/algorithms, 4) Details about how to build Laser Speckle Flowmetry and Diffuse Correlation Spectroscopy instrumentation, and 5) Diffuse optical tomography software.